Clinical Core

CLINICAL CORE PROJECT SUMMARY/ABSTRACT
The Clinical Core is the central component of the P30 Alzheimer’s Disease Research Center (ADRC). The
Clinical Core mandate is to provide resources to further the goals of the Center in understanding biological
pathways of Alzheimer’s Disease. The Core is a shared resource interacting closely with: the Outreach,
Recruitment, and Engagement Core (ORE) Core with regard to recruitment and training; the Database
Management and Statistical (DMS) Core with respect to data entry, storage and management; the
Neuropathology Core, through arranging brain autopsy and providing relevant correlative clinical data; and the
Biomarker, Genetics, and Neuroimmunology Cores through provision of DNA, plasma, blood cells, and
cerebrospinal fluid samples for biomarker, genetic, and immunological analyses. The Core will build upon its
29 years as a funded P50 ADRC, during which time it has enrolled more than 6,000 individuals, nearly 1,900 of
which are in the NACC Uniform Data Set (UDS) – with ethnic diversity including about 20% Hispanics and 11%
African Americans. The P30 Core will enroll 500 individuals in a new cohort: 100 new participants per year,
including 25 normal controls, and 75 persons with mild cognitive impairment or dementia. These participants
will each have extensive biomarker studies including research-grade 3T MRI, and lumbar puncture for
cerebrospinal fluid studies, and be followed annually. The Core will provide data to the DMS Core, transmitted
to the National Alzheimer’s Coordinating Center (NACC), and DNA for the Genetics Core, sent to the National
Centralized Repository for Alzheimer’s Disease (NCRAD). Evaluations will include detailed medical and
neurological interviews and examinations and neuropsychological testing, using NACC and Columbia site-
specific instruments. Biomarkers will flow to Biomarker, Genetics, and Neuroimmunology Cores, including
blood samples for plasma and peripheral blood cell populations, DNA preparation for genetic studies, CSF
specimens for spinal fluid cells and fluid biomarkers, and 3T MRI neuroimaging. The Clinical Core goals
include brain autopsies at the time of death, to provide neuropathological samples. The Core coordinates
closely with Administrative, Biomarkers, DMS, ORE, Genetics, Neuroimmunology, and Neuropathology Cores,
and with the REC module. Participants in the Core are informed of other trials and projects, and encouraged to
participate in these important imaging, instrument, drug study, and biomarker trials. The Clinical Core provides
training to students, residents, fellows, and investigators. Coded participant data, images, and biological
specimens, including plasma, DNA, CSF, and brain tissue are shared with ADRC, and other Columbia and
extramural investigators to improve diagnosis, understanding and treatment of aging and dementia, promoting
basic and translational research at Columbia, in the New York area, nationwide, and internationally.